IGF::OT::IGF - MODIFICATION 04: The purpose of this modification is to fund support NICHE Assessment Program for NIH SBIR Phase I (Under option year 2). The period of performance is September 28, 20

abstract